Core C: Maximizing Population Impact Core

MAXIMIZING POPULATION IMPACT CORE REVISED SUMMARY
The purpose of the Maximizing Population Impact Core is to maximize the effect of the Improving causal inference in AD projects for prevention research on modifiable risk factors: the Triangulation of Innovative Methods to End AD (TIME-AD) project on improving health for all populations. The Core will accomplish this ensuring health disparities are addressed whenever relevant in TIME-AD projects while collaborating with projects and cores throughout the analytic and dissemination stages to produce unbiased, high-impact scientific findings. This core will seek opportunities for more better data analysis approaches, such as settings where more representative data might be incorporated or added to enrich the broad relevance of study findings, and opportunities for analytics that would extend findings from non-representative samples to representative samples or entire populations. Once TIME-AD scientists have produced unbiased findings, the core will disseminate results to relevant constituencies who can use and act on the evidence. This includes identifying components of our work that should be shared with different target audiences, including researchers, the general public, clinical providers and health systems, community health advocates, media sources, or policymakers. This core responds to a well-recognized need to reduce AD/ADRD disparities and will ensure that TIME-AD projects findings are relevant to all populations and that they reach real-world constituencies in the most impactful form.